DP24-004, PRC: Core, University of Pittsburgh Health Promotion and Disease Prevention Research Center

PROJECT SUMMARY/ABSTRACT: Failure to equitably implement evidence-based healthcare interventions
and practices (EBIs) has perpetuated health and healthcare disparities in the US. Dissemination and
implementation science (D&I) strives to address evidence to practice gaps through the application of
implementation strategies—methods to address barriers that communities and people face adopting,
implementing, and sustaining EBIs. However, these strategies are often chosen without precision, failing to
account for local contexts, and thereby not improving disparities. Our University of Pittsburgh (Pitt) team has
expertise in cross-cutting D&I methods that can address multiple CDC priorities, including using novel and
human-centered methods to efficiently evaluate implementation determinants, empirically matching and
tailoring implementation strategies to these determinants to improve equity, and conducting rigorous
evaluations in the context of community-based participatory research (CBPR). Consistent with CBPR, our team
collaborated with Pitt's Family Medicine leaders and providers to select the Prevention Research Center (PRC)
Core Research Project goal to improve equitable Diabetes Self-Management Education and Support (DSMES)
program implementation. To achieve this goal, develop a PRC, and advance the PRC network, we will
leverage our broad bench of experts and apply theory-driven, pragmatic D&I methods to 1) Develop and
support the health equity and D&I focused Pitt PRC; 2) Co-develop, test, and disseminate implementation
strategies to support the adoption, implementation, and sustainment of EBIs to improve DSMES; and 3)
Actively participate in the PRC network to co-develop and deploy equity and D&I methods across Centers and
projects. In Aim 1, we will partner with the Pitt Clinical and Translational Science Institute (CTSI) and Pitt D&I
Science Collaborative (DISC) of over 170 D&I partners to develop and support a facile, sustainable Pitt PRC
that is poised to tackle emerging public health priorities. In Aim 2, we will work with community partners to
adapt an evidence-based implementation support approach to support DSMES program implementation,
leveraging our team's DSMES, human-centered design, and community engagement expertise. We will
conduct a hybrid type 3 cluster-randomized trial to test this bundle vs. usual approaches for supporting DSMES
program implementation across 24 family medicine practices, serving a total of 20,000 people with diabetes,
specifically aiming to improve implementation in Black and rural patients who are currently underserved by
standard approaches. In Aim 3, we will offer our team's expertise in CBPR, user-centered design, health equity,
and D&I as we collaborate with the PRC Network to adapt, implement, evaluate, disseminate, and translate
EBIs into clinical practice. We look forward to participating in PRC committees and conferences to share
information and data, develop new methods, and collaborate to advance precision implementation science and
public health.

Public health relevance
PROJECT NARRATIVE: We propose a University of Pittsburgh Health Promotion and Disease Prevention Research Center (Pitt PRC) that will address the urgent need to accelerate the implementation of treatments from evidence-based public health research to address the CDC's prevention and health promotion priorities and advance health equity. Drawing upon our team's expertise in health equity science, dissemination and implementation science, and community-based participatory research (CBPR), we will develop and offer pragmatic tools, methods, and technical assistance to increase capacity to conduct this work, for our Pitt Family Medicine and public health partners and across the PRC Network. Consistent with CBPR, our partners selected our Core Research Project to evaluate an implementation support tailored to improving Diabetes Self- Management Education and Support (DSMES) delivery in family practices that serve Black and rural patients.